Strategies to Help Adult ER Patients Quit Smoking

DESCRIPTION (provided by applicant): In urban communities, the prevalence of tobacco use among adults visiting a hospital emergency room (ER) nears 40%, well in excess of the 25% smoking prevalence rate of the general population. Many of these patients lack easy access to primary care, suggesting the ER may be an attractive locus to initiate tobacco cessation efforts. With over 100 million annual visits to U.S. ERs, it may be possible to engage millions of smokers in tobacco cessation efforts. The major purpose of this study is to examine whether a multicomponent intervention delivered in the ER by a Lay Educator to adult smokers interested in quitting is more likely to result in cessation than usual care. A secondary goal is to test whether patients who present to the ER with a tobacco-related illness (as indicated by ICD9 code) are more likely to quit than ER smokers with a non-tobacco-related condition. This will allow us to test the validity of the "teachable moment" as an opportune time to engage patients in considering a behavioral change. The proposed study is a randomized trial of a motivational interview, provision of literature, and post-visit follow-up (Enhanced Care) vs. referral to a cessation clinic (Minimal Care) for ER patients who smoke. Eligibility criteria: age >= 21 years, contemplation or preparation stage of change, not admitted to hospital. All patients will undergo a standardized stage of change assessment, and measurements of nicotine dependence and exhaled carbon monoxide. All will receive a cessation fact sheet and referral card to the smoking cessation clinic; the cards of those in the Enhanced Care group will have a specific appointment date and time. The Enhanced Care group will receive a language-appropriate pamphlet discussing smoking cessation. We will record the ICD9 codes associated with each visit. Major outcome measure: cessation within 3 months of the ER visit, stratified by treatment group. Secondary outcome measure: cessation within 3 months of the ER visit, stratified by whether the visit was smoking-related. If smokers receiving Enhanced Care are more likely to quit, then the ER could be considered a new, effective locus for tobacco control, potentially reaching several million smokers. If patients with a smoking-related diagnosis for the ER visit are more likely to quit than those with nonsmoking-related ICD9, then this supports the construct of the teachable moment.